Suppression of Host Antiviral Responses by a SARS-CoV-2 Histone Mimetic

PROJECT SUMMARY/ABSTRACT
Coronavirus disease 2019 (COVID-19) is caused by severe acute respiratory syndrome coronavirus-2 (SARS-
CoV-2) and has resulted in more than 1.4 million deaths globally. In contrast to other highly pathogenic influenza
viruses, SARS-CoV-2 infection is characterized by low levels of type I interferons and over production of pro-
inflammatory cytokines in patients. While concerted efforts have been made to understand the pathogenesis of
this virus, how SARS-CoV-2 is able to evade the innate immune response is unclear. The central hypothesis of
this proposal is that the envelope (E) protein of the virus interacts with BRD4 in a bromodomain-dependent
manner to disrupt the induction of host innate inflammatory and antiviral responses. This hypothesis is supported
by the recent proteomic study identifying this interaction and the presence of a histone H3-like motif containing
two lysine residues in the E protein. This model is also strongly supported by previous studies demonstrating
BRD4 as an important transcriptional coactivator of interferon and inflammatory genes during viral infection. The
central hypothesis will be tested in two specific aims: 1) To define the role of bromodomains in the interaction
between SARS-CoV-2 E protein and BRD4. The working hypothesis is that the lysine residues of the E protein
are acetylated and mediate interaction with the bromodomains of BRD4, acting as a histone mimetic. I will test
this model with label-free mass spectrometry to identify acetylated residues in E protein and immunoprecipitation
assays with domain constructs to characterize the interaction. 2) To determine the functional relevance of the
SARS-CoV-2 E protein and BRD4 interaction on the viral replication. The working hypothesis is that the E protein
acts as a histone mimetic to sequester BRD4 from chromatin thereby disrupting the transcription of pro-
inflammatory and interferon genes. I will use CRISPR/Cas9-mediated BRD4 knockout cell lines and BRD4
reconstitution studies in infected cells to test this model. My analysis will also focus on the transcriptional
activation of canonical pro-inflammatory and interferon genes along with the chromatin occupancy of BRD4 in
the presence of the E protein through RT-qPCR and ChIP-qPCR studies. I expect my proposed studies to inform
our fundamental understanding of coronavirus pathogenesis and provide novel therapeutic targets to combat
SARS-CoV-2 infection and immune evasion.

Public health relevance
PROJECT NARRATIVE The ongoing coronavirus disease 2019 (COVID-19) has resulted in over 1.5 million deaths worldwide and continues to spread uncontrollably in many countries. The proposed research will define the molecular mechanism in which the causative virus, SARS-CoV-2, is able to suppress antiviral responses within the cell to support viral replication. This project supports the NIH’s mission and aligns with one of its high-priority objectives to increase the fundamental and foundation knowledge of SARS-CoV-2 virology and immunological host response to infection.